Using Implementation Science to Increase PrEP Uptake among African American Women in the South - HIV/AIDS Supplement

Project Summary/Abstract This proposal is in response to: “Administrative Supplements to NIMHD Awards for Research on HIV/AIDS in Populations that Experience Health Disparities (NOT-MD-21-020).” The parent K01 award seeks to develop, test, and evaluate a PrEP Implementation Toolkit for staff in community healthcare clinics in the U.S. South to enhance PrEP access to African American women in the U.S. South. PrEP access for African American women in the U.S. may be disrupted by public health emergencies and sociostructural inequities influencing women’s healthcare experiences and overall wellbeing. This administrative supplement proposes an explanatory sequential mixed-methods design to assess the impact of a clinic-based intervention on PrEP uptake among African American women. Phase I: repeated cross-sectional surveys at baseline, 2- and 4-months (N=300) to assess the intervention’s impact on patient-level PrEP uptake (Aim 1). Phase II includes individual interviews to explicate survey findings (Aim 2). Integrating Social Cognitive theory, Social Stress theory and intersectionality, our proposed mixed-methods study will provide vital evidence of the intervention’s impact on patient-level outcomes within the context of national public health emergencies and sociostructural inequities. Findings from this proposed administrative supplement will strengthen the evidence of the clinical intervention’s impact to enhance PrEP uptake at both the clinic-level and among African American women patients.

Public health relevance
Project Narrative Pre-exposure prophylaxis (PrEP) may be a viable option for African American women at-risk for HIV infection, but few studies have identified optimal strategies to reach African American women in need of PrEP nor examined effective strategies to scale-up PrEP among African American women in the South. African American women in the South experience high rates of intimate partner violence (IPV) which could force women to choose between HIV prevention or IPV prevention. The proposed research study seeks to develop, pilot-test, and evaluate a PrEP Implementation Toolkit within two community healthcare clinics located in Jackson, Mississippi to increase PrEP uptake among African American, address IPV as a barrier to PrEP uptake, and ultimately combat racial disparities in women’s HIV diagnoses.